Using the gut microbiome to treat skeletal muscle atrophy

SUMMARY
When skeletal muscle is not used on a regular basis it becomes smaller as a result of myofiber atrophy; not
surprisingly, this muscle atrophy is accompanied by a loss of strength. Disuse atrophy is most often caused by
disease, surgery, injury or aging. Although there is a good understanding of the molecular mechanisms
underlying atrophy, and how they can differ given the cause, the development of an effective treatment
remains an ongoing challenge. Resistance exercise is currently the most effective treatment to help reduce the
level of atrophy and regain strength; however, many individuals are unable to perform exercise at a sufficient
intensity to promote muscle growth. Thus, there is a critical need to develop a new therapeutic approach to
work as an adjunct to resistance exercise or as a stand-alone treatment. Research over the last couple of
decades has provided a deeper understanding of how the gut microbiome impacts human health and disease
throughs its pervasive interactions with cells of the body via microbial-derived metabolites. Studies
investigating hibernating squirrels and germ-free mice have established a gut microbiome-skeletal muscle axis
involved in regulating skeletal muscle mass and function. We reported the disruption of the mouse gut
microbiome by antibiotic treatment blunted skeletal muscle hypertrophy in response to exercise training. We
have now acquired preliminary data showing cecal microbial transplant from exercised-trained mice to mice
undergoing unilateral hind limb immobilization, significantly reduced the magnitude of muscle atrophy.
Metagenomic and metabolomic analyses have identified promising candidate bacterial species and microbial-
derived metabolites, respectively, that we hypothesize mediate the observed reduction in muscle atrophy. To
test this hypothesis, we will first determine if cecal microbial transplant from exercise-trained mice also
attenuates muscle atrophy in male mice and fast-twitch muscles. We will also determine if mTORC1 activation
is the mechanism underlying the reduced muscle atrophy. We will next investigate if the administration of a
probiotic composed of candidate bacterial species, identified by metagenomics, is able to mimic the effect of
cecal microbial transplant by reducing muscle atrophy. A final aim will test if the administration of a post-biotic
(a microbial-derived metabolite identified by metabolomics) is capable of attenuating disuse atrophy. Regular
exercise is known to change the composition and function of the gut microbiome. Our preliminary data
provides compelling evidence that the gut microbiome of exercise-trained mice is able to significantly reduce
the magnitude of muscle atrophy following disuse. The proposed studies will determine if a probiotic and/or
post-biotic are capable of ameliorating muscle atrophy and preserving muscle function thereby providing a
novel therapeutic strategy to treat muscle atrophy.

Public health relevance
NARRATIVE When skeletal muscle is not used on a regular basis because of disease, surgery or injury, it becomes smaller (atrophy) and weaker. While resistance exercise is the most effective treatment for muscle atrophy, it is often not practical or possible for some people to do. Thus, the goal of this project is to determine if a probiotic or post-biotic (substance made by gut bacteria) can be used to treat muscle atrophy.